Educating Physician-Neuroscientists: The UE5 at UCSF

Project Summary/Abstract
The Department of Neurology at UCSF has been the institutional sponsor for the R25 program at UCSF over
the past 15 years and is the home department for this UE5 application. Neurology (including adult and child
neurology), Neurosurgery, and Neuropathology have all supported outstanding research training candidates
through this program.
The Departments of Neurology and Neurosurgery have an excellent record for attracting outstanding medical
students destined for these specialties, including many focused on physician-scientist careers. Neuropathology
attracts a similar cohort from pathology residencies to the neuropathology fellowship.
The neurology department aspires to train the next generation of national neurology leaders, and our neurology
residency graduates transition in high numbers to long-term academic careers as laboratory investigators,
clinical science (patient-based) investigators, as well as university-based clinician teachers.
The openings of the Sandler Neurology Research Building in 2012 and the Weill Institute for Neurosciences
Building in 2021 on the Mission Bay campus (see facilities below) have resulted in greatly expanded opportunities
for research trainees and collaboration between laboratory research programs in a common space and with
nearby research programs (e.g., Gladstone Institute, VA Laboratories at Mission Bay). The intellectual
environment is productive and exciting for trainees. Weekly multidisciplinary conferences (e.g., Seminar
Sessions and Grand Rounds) host speakers who discuss translational science issues that attract both clinicians
and bench scientists, and many of these programs are directed at the level of the trainee.
The current R25 program (transitioning to a UE5 mechanism) has been a crucial linchpin for the development of
research skills by our talented young physician scientists in neurology, neurosurgery, and neuropathology at
UCSF. In an era of increased competition for limited resources, the R25 has become a reliable source of
encouragement as well as a stable NIH program for ensuring that our most talented early career neuroscientists
are well-supported and well-mentored, allowing them to transition to a K award more successfully than ever
before.

Public health relevance
Project Narrative The increasing numbers of older adults in the United States continues to add to the societal burden of neurologic disease, but current treatments and prevention strategies are ineffective for many of these disorders, let alone those that impact children, adolescents, and middle-aged adults. By supporting early translational research training and experiences for young physician-scientists, the UE5 research education and research program continues to be an important mechanism for stoking the pipeline for physician-neuroscientists who will make important translational research discoveries that improve the future prevention and treatment of nervous system diseases. The translational neuroscience community at UCSF is positioned to expand the outstanding environment for the UE5 program by virtue of our commitment to training physician-scientists, demonstrated track record of success, new facilities, and the research accomplishments of our existing and new faculty.